ARGININE AMINOPEPTIDASES OF CRYPTOSPORIDIUM PARVUM

The role of proteases in Cryptosporidium parvum survival, attachment, and invasion are unknown. During the funded period of this MCAP study, further characterization of C. parvum aminopeptidase was accomplished. A specific role in parasitic excystation was identified and several inhibitory compounds were found to be effective in preventing amino- peptidase mediated excystation. In addition, basic biochemical characterization, a partial sequence was obtained from a genomic DNA library. Efforts to obtain the complete sequence and protein expression will continue to investigate the immunoreactivity of C. parvum aminopeptidase.